Loss of the Y Chromosome and Its Implications in Aging

PROJECT SUMMARY/ABSTRACT
Loss of the Y chromosome (LOY) is predominantly observed in the circulating white blood cells of older men,
suggesting a significant link to the aging process. LOY stands out as the most frequently observed non-
physiological postzygotic chromosomal alteration in the human genome. Its profound association with age and
age-related diseases presents a critical area for in-depth study to understand the broader context of aging. In
this proposal, our central focus lies in exploring the LOY-aging nexus. Utilizing both computational and hands-
on experimental strategies, we aim to achieve an integrated understanding of LOY. This encompasses novel
methodological innovations, rare variant association studies, and a meticulous probe into the mechanism binding
LOY with aging. By diving deep into this specific genome irregularity, we aspire to shed light on the intricate
effects of genetic factors that play out as we age. Our overarching goal revolves around demystifying the
interconnections between LOY, genome instability as one ages, and the onset of age-related diseases. Our
research hinges on two foundational hypotheses: first, that rare genetic variants play a pivotal role in LOY's
manifestation, shaping its appearance against the backdrop of polygenic risks set by more common variants;
and second, that LOY isn't an isolated event, but a piece in the larger puzzle of age-associated genome
instability. These suppositions draw strength from our preliminary data, garnered using SNP array genotyping
and whole exome sequencing from the Einstein longevity cohort. This invaluable dataset previously enabled us
to identify links between rare genetic variants and exceptional human longevity. We now set forth three distinct
aims: to ascertain the extent of LOY mosaicism using sequencing data; to pinpoint genes heightening LOY risk;
and, most crucially, to decode the relationship between LOY and aging. We firmly believe that a holistic
understanding of LOY's genetic blueprint and the mechanics tying it to aging will serve as a gateway to
understanding age-related pathology. A deeper insight into LOY will not only allow for precise quantification but
also pave the way for innovative therapeutic strategies, potentially offering a novel approach to mitigate the
challenges of aging and age-associated diseases.

Public health relevance
PROJECT NARRATIVE Our research holds significant public health relevance as we aim to investigate the genetic foundations of the loss of chromosome Y (LOY) and its connections to the aging process. This exploration is pivotal for deciphering LOY's role in the susceptibility to diseases linked with aging. Directly aligning with the NIA's mission, our study seeks to cultivate foundational insights that can mitigate the challenges and disabilities humans face in their later years.